NEUROENDOCRINOLOGY OF ALCOHOLISM

Study frequency of both diurnal rhythm and response abnormalities of anterior pituitary and end-organ hormones in alcoholic patients during and after acute withdrawal, their locus of disturbance, and their persistence over time.